Cancer Center Support Grant

Abstract Overall
The City of Hope Comprehensive Cancer Center (COHCCC) received NCI-designation in 1981 and
Comprehensive status in 1998. Led by Steven T. Rosen, MD, the COHCCC is composed of 175 full Members,
five productive Research Programs, eleven established Shared Resources and one developing Shared
Resource, a robust cancer-focused research funding base (76% growth in NCI funding in the current funding
cycle), and an active clinical trials portfolio that builds on institutional research discoveries. The COHCCC
facilitates advances across the translational research continuum by providing infrastructure, strategic planning,
administrative support, and mechanisms for transdisciplinary interactions that catalyze cancer-focused activities
traversing basic discovery, clinical, and population-based investigations. These activities are aligned to reduce
cancer burden of a highly populated and diverse Catchment Area of nearly 18 million people that encompasses
33,109 square miles and ranges from urban population centers concentrated in Los Angeles and Orange
Counties to rural and frontier regions in eastern San Bernardino and Riverside Counties. To foster high-impact,
transdisciplinary cancer-focused research, the COHCCC leverages a spectrum of state-of-the-art Shared
Resources including in-house GMP manufacturing facilities; informatics and precision medicine resources;
notable breadth and depth of in-house experience in conducting clinical trials; and a centralized administrative
infrastructure. The COHCCC is also committed to developing and enhancing the diversity of the next generation
of leaders in basic, clinical, and population-based cancer-related research through robust training initiatives that
begin at K-12 outreach and continue through junior faculty development. To enhance cancer prevention, improve
early detection, and accelerate translation of novel therapeutic approaches that impact patients across the
lifespan and from diverse populations, the COHCCC will pursue the following Specific Aims: 1) Identify, develop,
produce, and advance first-in-field and first-in-human new treatments; 2) Implement four strategic initiatives:
advancing precision medicine, expanding cellular therapeutics, promoting health equity, and enhancing clinical
research in the clinical network; 3) Assess and address the cancer burden in the COHCCC Catchment Area,
promoting early detection, prevention, novel treatments, aging, and survivorship; 4) Advance training and
educational initiatives to support the next generation of cancer-focused scientists and clinicians; 5) Enact
concrete policies to enhance diversity, equity, and inclusion in the COHCCC Membership and Leadership.
During the next cycle, the COHCCC will expand on historic strengths and advance critical initiatives that will
benefit the diverse population of the Catchment Area and the larger community of individuals at risk for or
affected by cancer.

Public health relevance
Narrative Overall The City of Hope Comprehensive Cancer Center leverages the scientific expertise of 175 cancer-focused investigators who form five productive Research Programs spanning basic, translational, clinical, and population- based research that are supported by unique institutional resources and a robust cancer-focused research funding base. An active clinical trials portfolio builds on institutional research discoveries to facilitate advances across the translational research continuum that benefit the population of a diverse Catchment Area and the larger community of people at risk for or affected by cancer.